AI-Campus Workshops: Revolutionizing Healthcare with AI and Machine Learning to Promote Diversity and Inclusion

Project Summary
The healthcare sector is undergoing a transformation driven by artificial intelligence and machine learning
(AI/ML) technologies, which offer potential for enhancing research, optimizing patient outcomes, and increasing
healthcare systems' efficiency. However, many researchers, especially from underrepresented communities,
face limited access to resources and opportunities in this field. We propose a multi-faceted approach to promote
diversity and inclusion, including online competitions and annual workshops catering to a wide range of
participants. We have a strong track record of engaging with Historically Black Colleges and Universities
(HBCUs) through AI-Campus and national competition organization experiences. We have organized events
such as the iDASH genomic privacy workshop and encouraged students to participate in the Dream challenge.
Partnering with HBCUs has increased interest in AI/ML and diversity in the field. Our proposed series of events,
"AI-Campus Workshops: Revolutionizing Healthcare with AI and Machine Learning to Promote Diversity and
Inclusion," will build upon this track record of success. Aim 1 focuses on creating annual competitions for
healthcare outcome improvements, designing datasets that represent real-world problems, and providing
opportunities to underrepresented participants. Aim 2 involves organizing annual workshops on the latest AI/ML
advances in healthcare, inviting diverse speakers, and offering experience with the latest tools and technologies.
Aim 3 centers on engaging with Minority Serving Institutions (MSIs), such as Historically Black Colleges and
Universities (HBCUs) and Hispanic Serving Institutions (HSIs), to ensure diverse representation in our AI/ML
healthcare initiatives. Through these aims, we will empower participants with essential skills, knowledge, and
connections needed to excel in the healthcare AI/ML landscape. Our vision is to foster a vibrant and inclusive
community of researchers and practitioners committed to advancing AI/ML in healthcare. By facilitating diverse
participation, education, and collaboration, we aim to make a significant impact on AI/ML for healthcare and
nurture a diverse, inclusive community that propels progress and innovation in healthcare to benefit everyone.

Public health relevance
Public Health Relevance/Narrative This project proposes AI-Campus workshops to revolutionize healthcare with AI and machine learning to promote diversity and inclusion. It uses a multi-faceted approach that encompasses a series of events, including online competitions and workshops. It helps providing more opportunities for junior and underrepresented researchers to engage with AI in healthcare.